Chromatin Dynamics and Genome Regulation

Mammalian development results in the specification of over 200 different cell types from a single genome, with
subsequent maintenance of cell identity in adult organisms. The genomes of eukaryotic cells are packaged into
a dynamic chromatin structure, which allows cells to control the accessibility of all DNA encoded information.
The selective incorporation of specialized histone proteins, or variants, into this dynamic genomic structure is
an important feature of epigenetic regulation. A main focus of my lab is one such protein, the histone variant
H3.3. The identification of mutations in H3.3 and associated proteins in human cancers and developmental
disorders has heightened the pressing need to understand the role of this histone variant in normal
development and adult homeostasis. Although H3.3 is critical to cellular function in multiple contexts, how H3.3
contributes uniquely to chromatin function is a long-standing, unanswered question in the field. While long
associated with gene activation, recent studies establish that H3.3 also deposited at repetitive, heterochromatic
regions of the genome, with deposition at each region facilitated by independent chaperone complexes. We
still do not know how H3.3 is partitioned between its two chaperone complexes, or how this equilibrium
influences cellular function. Once deposited, our studies and others have demonstrated that H3.3 influences
the chromatin modification landscape at both euchromatin and heterochromatin. Our data suggest that H3.3
can perform this function directly at euchromatin via phosphorylation of a unique serine that influences the
activity of a histone acetyltransferase or indirectly at heterochromatin through chaperone-mediated recruitment
of a co-repressor complex. Despite these intriguing observations, we do not yet fully understand the detailed
mechanisms by which H3.3 deposition influences chromatin states. Finally, we do not understand how H3.3
performs its myriad functions in the context of complex, multicellular organisms. The goals of this proposal are
to: (1) understand how H3.3 chaperone complex equilibrium is established, and determine the effects of
disequilibrium on cell function, (2) determine the molecular mechanisms by which H3.3 influences local
chromatin landscapes, and how these events influence downstream genome usage, and (3) make use of our
novel mouse models to understand the role of H3.3 in adult organisms, including adult stem cells. Our
proposed research is significant because it will serve as a platform to understand epigenetic regulation of cell
identity in both normal development and adult homeostasis, and by extension, developmental misregulation
and disease states.

Public health relevance
The purpose of this research proposal is to study the role of chromatin dynamics in genome regulation and cell fate decisions. The proposed research is relevant to public health because many of the proteins studied are mutated in human cancers, including pancreatic neuroendocrine tumors and pediatric glioblastomas. Understanding the normal physiology of these proteins will lead to greater insights and therapeutic opportunities in disease states.